Mathematical modeling of metabolism rewiring in cancer eco-evolution and metastasis tropism

SUMMARY
It is critically important to establish the causes of organ-specific metastasis; without this knowledge, prevention
and timely treatment of metastatic cancer will likely remain limited. This application aims to develop novel
mathematical models to understand how a rewired cellular metabolism enables cancer cells that originate in
one organ such as the breast to colonize distal organs such as the lung, the brain, and the bone, which have
distinct microenvironments. We will study metabolic rewiring in parental cells and their metastatic derivatives
and ask how metabolic gradients in the primary tumor can generate and maintain diverse lineages with specific
metabolic adaptations for organ-specific metastasis. Our central hypotheses are 1) that metabolic adaptations
are key to the match between the seed (the disseminated cell) and the soil (the distal site) in metastatic breast
cancer, and 2) that the metabolic microenvironment in a primary tumor drives metabolically diverse
subpopulations. The hypotheses have been formulated based on 1) published data detailing metabolic
heterogeneity and that metabolic adaptations can promote metastasis, 2) preliminary data and analysis of RNA
expression, metabolomics, and flux measurements, revealing different metabolic adaptations in breast tumor
cells that home to different tissues, and 3) preliminary data showing that metastatic lineages respond
differently to hypoxia and nutrient gradients, indicating a role for the metabolic microenvironment in maintaining
diverse subpopulations within the same heterogeneous primary tumor. Mathematical modeling is critical to
integrate experimental data and infer changes in metabolic fluxes that cannot be directly measured. The
application proposes a research strategy that combines experimental, clinical, and mathematical analysis to
identify new vulnerabilities in metastatic cancer cells. We will also develop novel mathematical models to study
the ecological interactions between cell lines and their microenvironment and determine the conditions that
lead to coexistence of metabolically distinct pre-metastatic subpopulations in the primary tumor.

Public health relevance
NARRATIVE Metastasis is the major cause of cancer-related death, but the metabolic adaptations that enable a cancer cels originated from one organ to grow in a distal organ remain unclear. Here, we propose to develop new mathematical models to infer the metabolic fluxes rewired in metastasis, knowledge that may open new strategies to prevent and treat metastatic cancer.